Word Retrieval in the Wild: Establishing Preliminary Efficacy of Semantic Feature Ecological Momentary Intervention for Post-Stroke Aphasia.

PROJECT SUMMARY
Anomia (i.e., impaired word retrieval) is one of the most common and debilitating deficits experienced by stroke
survivors with aphasia, an acquired disorder characterized by impaired language. Although many anomia
treatments exist, treatment response is modest and inconsistent across studies, and the extent of generalization
to everyday contexts—the therapy gold standard—is largely unknown. The critical gap between actual outcomes
and the therapeutic potential of naming therapy is tied to problems with current treatment delivery practices (i.e.,
low/unknown dosage, massed practice delivery, and decontextualized training). In this research, we aim to
demonstrate that a novel smartwatch-based ecological momentary intervention (EMI) that delivers high-dosage
semantic feature training throughout daily life has the potential for overcoming these issues. Every day for six
weeks, 20 PWA will complete 24 trials of semantic feature EMI distributed over the day (from 10am-8pm) and
delivered by a smartwatch. The EMI trial flow will include five steps: 1) a prompt alert and audiovisual “Ready to
name a picture?” cue, 2) a first naming attempt after a YES response, 3) the repetition of an auditory model, 4)
semantic feature verification via yes/no questions, and 5) a second naming attempt. To contextualize training
further, trained items will be clustered into location categories (e.g., home, pharmacy), and we will use the mobile
device’s location detection to match PWA’s location and item category for ~50% of trials. In Aim #1, we will
establish preliminary efficacy of this EMI by determining the extent to which semantic feature EMI improves
naming of trained items and generalizes to untrained, related contexts. We predict that the EMI will significantly
improve 1) naming of trained items and semantically related, untrained items relative to semantically unrelated
items and 2) subjective and objective measures of functional communication effectiveness. Given the novelty of
our EMI, the second two aims will focus on identifying key factors of semantic feature EMI user experience (Aim
#2) and trends between therapy response and the treatment delivery factors of dosage, trial spacing, and item-
location congruence (Aim #3). The proposed research is innovative because of the novel use of EMI for aphasia,
our combined application of distributed practice and context-dependent training, and the future promise of
extending our system to other types of evidence-based treatment and to other clinical populations, as well as to
in-situ “just-in-time” interventions that can intervene in real time during the moment of communication breakdown.
The significance of this research lies in its ability to provide technology that automatically tracks dosage metrics;
its potential for increasing knowledge regarding which therapy delivery factors impact outcomes; and its promise
for providing PWA alternative paths to receive therapy. Successful completion of this research will lead to an
R01 application aimed at establishing the efficacy of this novel therapy compared to gold-standard, clinician-
provided treatment and determining which active treatment ingredients contribute to outcomes.

Public health relevance
PROJECT NARRATIVE One of the most common post-stroke conditions that contributes to long-term disability is aphasia, a language disorder that has devastating impacts on communication and quality of life. Currently, response to speech- language therapy varies widely between people, so ensuring all people with aphasia receive the right treatment at the right dose is a major health priority. In this research, we aim to demonstrate that a novel technology platform that delivers language therapy at a high dose throughout the day during daily life has the potential for overcoming current dosage and aphasia treatment delivery challenges that have limited language outcomes for people with aphasia.